Shared Resources - 001: Bio Statistics

PROJECT SUMMARY/ABSTRACT
The Biostatistics Shared Resource Core (BSRC) serves a critical role in enhancing the U54 research
infrastructure. The BSRC is led by biostatisticians who have the expertise and experience to contribute
substantially to successful cancer research in Pacific Island populations. The BSRC adds to the scientific rigor
of U54 research through sound statistical advice and inclusion of novel approaches, such as Respondent
Driven Sampling and an interim analysis scheme in current projects. The BSRC provides support for all
quantitative aspects of research endeavors, including study design, data management, statistical
programming, data analysis, and interpretation and presentation of results. A primary biostatistician is assigned
to each U54 research project in order to provide consultation throughout the study. The BSRC Leaders serve
as non-voting members of the U54 Internal Advisory Committee and provide statistical review of, and input to,
new research concepts. The Shared Resource builds capacity for health disparities research at University of
Guam and the University of Hawai`i Cancer Center through mentoring of faculty and students on quantitative
methods, thus building research capacity, and through formal seminars. Additionally, the BSRC will facilitate
research through curation of information on cancer risks and prevalence of cancer risk and protective factors in
Guam and Hawai`i to be used to inform research projects and through creation, with the Information
Technology Shared Resource, of a platform for storage and sharing of current and past U54 project data and
documents.